Clinical effectiveness of a wearable hydration device

Executive Summary of Predicate STTR Phase 1 Grant and Team
This application seeks supplemental funding for growing our business around an innovative approach
to measuring hydration. Our company is seeking STTR funding to refine our technique and
demonstrate its utility in an area of high clinical need, in partnership with an academic medical center.
At TritonX we believe that the future of health & wellness is in continuous monitoring. Monitoring
hydration is a daily challenge for millions of people, especially older adults and people with common
chronic diseases - migraines, kidney disease, heart disease, diabetes and other serious conditions. We
have developed a wearable continuous hydration monitor that can detect users’ total body water,
intracellular and extracellular water in real time to help them lead a better life, ward off diseases and
maintain or improve their quality of life. Our company seeks to eliminate the burdens caused by
dehydration not only on individuals but also on the health care system.
Progress toward aims of our Phase I aims:
Aim 1: Determine the ideal user experience, device settings and health care communication needs
when conducting continuous monitoring of fluid levels among older adults in their homes.
Progress: We have redesigned our prior prototype device, removing unnecessary features and
upgrading components to increase efficiency and reliability for the current study. The improved device
will enable us to better focus on customer experience as opposed to technical support.
Aim 2: Compare device measured fluid levels to clinical and laboratory parameters pre and post
treatment among acutely ill older adults presenting to the emergency department for dehydration.
Progress: We have established protocols and identified team members to conduct our study in the
proposed emergency care environment. IRB approval is complete. We have trained staff on protocols
using our device.
I-Corps Team
Our I-Corps team:
• Corporate Officer: Dr Éamon Johnson, CEO TritonX Inc
• Technical Lead: Shravan Khare, CTO TritonX Inc
• Industry Expert: Greg Davis, advisor to TritonX Inc
Dr Johnson and Mr Khare are founders of TritonX Inc and have devoted substantial personal resources to
development of the small business and the technology. Mr Khare is the inventor of the technology. Mr Davis is
an investor and advisor with TritonX with 25 years of experience in medical software sales and marketing. Dr
Johnson and Mr Davis have worked closely for six years in research commercialization in health software.
The team is committed to the success of the company and ready to commit to the I-Corps program fully. We
view the program as an essential learning opportunity and look forward with great anticipation to the process of
customer discovery. We are committed to thorough re-evaluation of our value proposition in light of the market
reality we will discover through the I-Corps process.